Implementing and Sustaining a Transdiagnostic Sleep and Circadian Treatment to Improve Severe Mental Illness Outcomes in Community Mental Health.

!
Abstract
An obstacle to the roll-out of evidence-based treatments (EBTs) for severe mental illness (SMI) is that the
context for the implementation typically differs from the original testing context causing a lack of “fit” between
the setting and the EBT. We propose to evaluate if adapting a specific treatment to improve the contextual fit
improves outcomes in a setting that typifies this challenge—community mental health centers (CMHCs).
Following the Experimental Therapeutics Approach, the target is sleep and circadian dysfunction. In SMI,
sleep and circadian dysfunction undermines affect regulation, cognitive function and physical health, predicts
the onset and worsening of symptoms and is often chronic even with evidence-based SMI treatment. Prior
treatment studies have been disorder-focused—they have treated a specific sleep problem (e.g., insomnia) in
a specific diagnostic group (e.g., depression). However, real life sleep and circadian problems are not so neatly
categorized, particularly in SMI. Hence, we developed the Transdiagnostic Intervention for Sleep and Circadian
Dysfunction (TranS-C) to treat a wide range of sleep and circadian problems experienced in SMI.
With NIMH support, including a study in CMHCs, we established that TranS-C engages the target. Yet gaps
remain: 1) Thus far, the TranS-C providers have been employed, trained and supervised by the university. We
will determine if TranS-C can be effectively delivered by providers within CMHCs. 2) We will test a version of
TranS-C that has been adapted to improve the fit and to address potential barriers to scaling TranS-C. The
rigorous adaptation process used theory, data and stakeholder inputs. 3) We will study ad hoc adaptations
made by providers to TranS-C. 4) We include two stages; namely, the Implementation Phase (2 years) and the
Sustainment Phase (1 year). The latter responds to urgent calls to study the sustainability of EBTs.
Guided by the Replicating Effective Programs (REP) framework, in this Hybrid Type 1, 4-year study, 8 CMHC
clinic sites will be cluster randomized to either Standard or Adapted TranS-C. Then, within each CMHC site,
patients will be randomized to immediate TranS-C or to Usual Care followed by Delayed Treatment (UC-DT). A
total of 96 providers and 576 patients will participate. Patients will be assessed pre, mid and post-treatment
and at 6 months follow-up. UC Berkeley will co-ordinate the research, facilitate implementation, collect data
etc. Providers within an established network of CMHCs will implement TranS-C. SA1 is to confirm that both
Standard vs. Adapted TranS-C, compared to UC-DT, improve sleep and circadian functioning and reduce
functional impairment and disorder-focused psychiatric symptoms. SA2 is to evaluate the fit, to the CMHC
context, of Standard vs. Adapted TranS-C. SA3 will examine if better fit mediates the relationship between
treatment condition and patient outcome. This research will determine if sleep and circadian problems can be
effectively addressed in SMI in CMHC settings, test two variations of TranS-C that each have unique
advantages and focus on community providers and typical community patients.

Public health relevance
! Project Narrative The sleep disturbance commonly experienced by individuals with a severe mental illness (SMI) reduces their capacity to function and contributes to key symptoms. This study will test the effects of a sleep treatment that has been adapted using theory, data and stakeholder inputs to improve the fit for SMI patients treated in community mental health centers (CMHCs), relative to the standard treatment. We will also determine if the adapted and standard versions can improve sleep, improve functioning and reduce symptoms.